Outreach, Recruitment & Engagement Core

PROJECT SUMMARY - OUTREACH, RECRUITMENT, AND ENGAGEMENT CORE (CORE E)
The overall goal of the Outreach, Recruitment, and Engagement (ORE) Core is to improve the care provided to
persons and families affected by Alzheimer's disease (AD) and related dementias by recruitment of individuals
into Alzheimer's Disease Research Center (ADRC)-sponsored studies, disseminating information, and
translating new knowledge into practice for researchers, health care professionals, trainees, and the general
public. The activities of the ORE Core represent a collaborative initiative involving the Divisions of Geriatrics and
Gerontology, Wisconsin Alzheimer's Association Chapter Network (WAACN), Office of Continuing Professional
Development in Medicine and Public Health (OCPD), State of Wisconsin Department of Health Services (DHS),
Wisconsin Geriatric Workforce Enhancement Program (GWEP), communities throughout Wisconsin, and the
extensive outreach, education, and dementia diagnostic clinic programs of the Wisconsin Alzheimer's Institute
(WAI). These collaborations represent a unique leveraging of resources to expand the influence of the ORE Core
beyond the walls of the University of Wisconsin School of Medicine and Public Health. The ORE Core is fully
integrated into the Clinical, Neuropathology, Data Management and Statistical, and Inclusion of
Underrepresented Groups Cores. Working together, the Core has been able to identify and resolve the barriers
to research participation by a diverse study population. Our successful recruitment efforts are matched by our
clinical and research education and training programs and statewide outreach and professional education
programs of the WAI.
Over the past nine years, the Core's outreach, recruitment, and education programs have worked to achieve the
stated goals of the National Alzheimer's Project Act (NAPA) by enhancing public awareness and engagement,
optimizing care quality and efficiency, and working with health providers and state government to expand
supports for persons with AD and their families. The Core has made major contributions to NAPA's primary goal
to prevent and effectively treat AD by 2025 by supporting clinical trials and the study of preclinical AD, mild
cognitive impairment, and AD at the Wisconsin ADRC and WAI (Wisconsin Registry of Alzheimer's Prevention:
Biomarkers of Preclinical AD, RO1AG27161 [2-4]). These efforts and collaborations will be expanded during this
renewal, and new programs such as a participant advisory board will be implemented to ensure ongoing success
of the ORE Core and responsiveness to stakeholder interests.